Mechanisms and consequences of antigen-dependent T cell homing for adoptive immunotherapies

Project Summary/Abstract
Adoptive cell therapy (ACT) with activated and expanded T or CAR T cells may be used to treat infections or
tumors and ACT with T or CAR T regulatory cells are in clinical trials to control autoimmunity and allograft
rejection. Many but not all patients benefit. The success of ACT depends upon T cell homing to relevant tissue
sites. Normal circulating T effector memory or T regulatory cells can enter a tissue in response to their cognate
antigen being displayed on the surface of the local microvascular ECs in a process triggered by TCR and
modulated by costimulation. We hypothesize that antigen presentation by human endothelial cells (ECs)
will recruit adoptively transferred in vitro expanded T or CAR T effector and regulatory cells to specific
peripheral tissue sites in a process modulated by specific EC co-stimulators. In specific aim 1, we will
test this hypothesis in vitro in models we have developed using endothelial cell monolayers in flow chambers
to model in vivo conditions. We will expand our in vitro assys to include an examination of the effects that TCR-
induced transendothelial migration (TEM) has on the T cells at the single cell level. In the case of CAR T cells,
we will determine the most important costimulator receptor molecule motifs to be incorporated into the CAR for
optimal TEM. We will also determine if human ECs have the capacity to cross-present or be “cross-dressed” by
antigens allowing EC presentation of antigen to influence cancer immunotherapy. Finally, we will use a model
we developed for studying adoptively transferred human T cell responses to synthestic microvessels
assembled from human ECs, allowing genetic manipulation of the signals human ECs can provide. In aim 2
we will conduct similar experiments using T and CAR T regulatory cells. Successful completion of these aims
will provide important information for extending the range of patients who may benefit from ACT.

Public health relevance
Project Narrative A major advance in using immunology to treat disease has been giving patients T cells that have been expanded in the laboratory and are specific for an antigen associated with the patient's medical condition, using either naturally antigen-specific T cells or using gene transfer to make the T cells specific for a particular antigen. Not all patients benefit from these therapies partly because the administered T cells must also have the right machinery to go to the site where they are needed. Antigen displayed on the lining of the local blood vessels normally can direct T cell homing to the right sites and, in this application, we will determine if the same process can also direct homing of expanded T cells, and if so, how to make it more efficient.